Operation and Maintenance of the Biological Data and Processing System

This contract provides software engineering, database design, mathematical and statistical support to the Developmental Therapeutics Program (DTP) in its drug discovery and development efforts. This includes design and or/redesign of application programs as well as initial coding, revising, testing, documenting, operating and maintaining all custom software.